Functional characterization of mesenchymal-epithelial transition (MET)-derived cells in normal endometrial regeneration

PROJECT SUMMARY
The uterus in women is a unique organ in its ability to undergo repeated physiological damage and repair during
the monthly menstrual cycle. The endometrium, in particular, is extensively regenerated following menstrual
shedding. Our long-term research goal is to understand the normal mechanisms of endometrial regeneration
and repair and how these processes, when mis-regulated, contribute to diseases/dysfunction such as
endometrial cancer, endometriosis, thin endometrium, Asherman’s Syndrome and infertility. In this project,
experiments are designed to investigate mesenchymal-epithelial transition (MET) as a mechanism of
endometrial epithelial regeneration. Research shows that MET is one mechanism by which the endometrial
epithelium is regenerated postpartum and in a menses-like model in mice and has been proposed as a
mechanism in women. During MET, which is a type of cellular transdifferentiation, a mesenchymal cell is
reprogrammed and converted into an epithelial cell. To our knowledge, the endometrium is the only tissue that
uses cellular transdifferentiation under normal physiological conditions (e.g. postpartum and menses-like repair)
in the adult. Unfortunately, our understanding of this unique repair mechanism is very incomplete. Two specific
aims will further investigate MET in epithelial regeneration: (1) Test the function of MET-derived endometrial
epithelial cells; and (2) Compare MET by endometrial-derived and bone marrow (BM)-derived mesenchymal
cells. A combination of mouse models including lineage tracing, menses-like endometrial breakdown and repair
and a novel orthotopic transplantation technique along with scRNA-seq will be employed to address fundamental
questions about the function, characteristics, and origin of MET-derived epithelial cells. Particularly, whether they
are bona fide endometrial epithelial cells and whether they originate from endometrial stromal cells and/or bone
marrow cells, will be investigated. Importantly, orthotopic transplantation will be used to assess MET by human
stromal cells as in vivo studies cannot be performed in women. Proper endometrial regeneration, including
replacement of lost or damaged epithelial cells, is necessary for preparation of the uterus for subsequent
reproductive cycles and pregnancy. No other organ is subject to such extreme tissue regeneration as that seen
in the uterus during the menstrual cycle. It is perhaps because of the extent of damage and repair that the uterus
undergoes that it is subject to development of diseases. Increased understanding of endometrial repair
mechanisms will provide greater insight into how these processes, when gone awry, contribute to endometrial
diseases and impact fertility ultimately leading to better therapeutics.

Public health relevance
PROJECT NARRATIVE Proper endometrial repair after menstruation is necessary to allow for subsequent menstrual cycles and pregnancy. The uterus is prone to diseases including endometrial cancer and endometriosis that may result from improper regulation of endometrial repair. This work will provide important information about normal endometrial repair mechanisms so as to better understand how mis-regulation may contribute to uterine diseases and infertility in women.